Neuronal and glial mechanisms regulating Pair1 local pruning

Project Summary
Developing brains over-wire and create excess synaptic connections. The nervous system then undergoes
neuronal remodeling by implementing structural changes through pruning of superfluous neurons and synapses.
Neurons and glia communicate intensively during the remodeling process, but the mechanistic basis of neuronal
or glial signaling remain understudied and poorly defined. Disrupted remodeling has implications on behavior
and circuitry in neurodevelopmental disorders, like autism spectrum disorder (ASD), and even
neurodegenerative diseases like Alzheimer’s, highlighting the importance of defining this process.
There are strong correlations between broad changes in neural circuit connectivity and behavioral
changes in ASD animal models and patients. This has led to the proposal that broad changes in neuronal
remodeling during development cause behavioral changes, but this idea has not been tested directly and the
link between structural changes in circuits (e.g. local pruning of neurites) and behavior remains unclear.
Drosophila Pair1 neurons, a circuit where 6 neurons drive reversal behavior in the larva and adult, provide an
excellent model to study both neuronal and glial molecular mechanisms of remodeling, and investigate how
perturbation of remodeling affects behavior and circuit morphology. In preliminary work I have defined the
morphology of their local pruning and identified caspase signaling as a key neuron-intrinsic pathway that drives
pruning.
In Aim 1, I will investigate intrinsic mechanisms for Pair1 local pruning by exploring known caspase
cascades in the context of Pair1 pruning using loss-of-function studies and caspase indicators with live ex-vivo
imaging. In Aim 2, I will determine if astrocytes are responsible for activating Pair1 remodeling and clearing
pruned debris, and conduct a targeted genetic screen for glial molecules required for pruning of Pair1 neurons.
In Aim 3, I will block intrinsic remodeling cues in Pair1 neurons to ask if altering Pair1 local pruning affects
assembly of adult circuitry and behavior. Together, these aims will contribute new fundamental knowledge to the
remodeling field, which ultimately will help us understand how brain circuits are optimized and how changes in
remodeling might affect behavioral phenotypes in neurological disorders and disease.
The training potential for me is very high in this project, and my proposed research will help me achieve
both my research and professional training goals. I will deeply expand my knowledge in both the glial and
neurodevelopmental biology fields, while also gaining many new technical skills in the laboratory. Outside of the
laboratory, I will consistently seek career development opportunities to advance my communication skills,
leadership, and equity and inclusion education and impact. I am strongly supported in my training goals from my
sponsor Dr. Marc Freeman, the Vollum Institute, and OHSU and know I will succeed with the support of this
award.

Public health relevance
Project Narrative During early development, nervous systems are over-built, and then undergo a period of refinement by “pruning” that helps optimize neural circuit function, but how this is regulated remains unclear. I will use a uniquely identifiable neuron (Pair1 neurons) that undergo extensive pruning and regrowth, to identify new remodeling pathways. In addition, I will block the ability of these neurons to remodel and ask how blocking structural changes that occur during development ultimately affect adult nervous system function.